Identification of environmental chemicals capable of inducing health impairments acutely and across generations

SUMMARY
Epidemiological evidence suggests that parental environmental exposure correlates with
increased risk of chronic diseases in children and even grandchildren. Animal studies provide
clear evidence that ancestral exposure to chemicals such as endocrine disruptors, dioxins, or
pesticides can induce non-Mendelian (but heritable) health impairments across generations.
Most research thus far has focused on rodents, which imposes limits of a few compounds at a
time in small numbers of animals and statistically sound experiments covering multiple
generations require years. Thus, comprehensive attempts to identify chemicals capable of
inducing intergenerational effects have been completely lacking. Importantly, the mechanisms
by which parental exposure leads to heritable health effects in subsequent generations
are still poorly understood. The objectives of this project are to 1) develop and verify a new
high-throughput fruit fly (Drosophila) model for chemical exposure and intergenerational health
effects, and 2) identify reprograming signatures to help uncover potential biological mechanisms
for transmitting those non-genetic effects from parent to offspring.

Public health relevance
Project Narrative Evidence suggests that parental environmental exposure correlates with increased risk of chronic diseases in children and even grandchildren. There is therefore a critical need for a novel approach to comprehensively estimate the frequency and severity of such intergenerational effects. We will thoroughly test environmental chemicals found in the blood and urine of the U.S. population (Fourth National Exposure Report) for their ability to induce defined behavioral, metabolic, and immune phenotypes, both acute and across generations.